A Systems-Level Intervention for Rural Adults - Administrative Supplement

Addie Weaver (PI); K01MH110605
NOT-MH-21-120: K01 Supplement Due to COVID-19 Disruption
Abstract
This Administrative Supplement due to COVID-19 Disruption seeks to provide five months of additional salary
support to the Principal Investigator in completing her Mentored Research Scientist Career Development
Award focused on developing and testing a technology-assisted cognitive behavioral therapy for depression,
tailored for the rural context and for delivery by clergy. The proposed mentored research, informed by the
the Replicating Effective Programs framework (REP) and CBPR, aims to (1) adapt and package group CBT for
depression for delivery by clergy, and conduct an open pilot test of the adapted intervention; (2) conduct a pilot
randomized controlled trial (pRCT) to assess the intervention’s preliminary effect on depression and explore
the relationship between potential mechanisms of change and expected outcomes; and (3) explore intervention
acceptability and feasibility using mixed methods to assess multiple stakeholders perceptions of the
intervention and its implementation. The Principal Investigator made substantial progress in completing these
aims. She developed the intervention, Raising Our Spirits Together, and successfully piloted it with extremely
promising results. The randomized controlled trial (RCT) is underway, with 28 participants, or 33.3% of the
required sample, enrolled in the study. However, the COVID-19 pandemic resulted in substantial delays to the
project, given the stoppage of in-person research activities in March 2020. As a result, the Principal
Investigator adapted this important research for completely virtual engagement with participants. This required
significant time and effort to assess the feasibility of virtual delivery, adapt all study protocols and procedures,
and obtain Institutional Review Board approval for all changes. Additionally, virtual recruitment efforts resulted
in slower recruitment flow than anticipated in our targeted rural communities, delaying recruitment milestones
originally expected for the RCT. The Principal Investigator has obtained approval to conduct in-person
recruitment following safety protocols in order to facilitate engagement with rural residents in the study’s target
communities. The newly approved in-person recruitment efforts resulted in recruiting six participants in a one-
month period. This Administrative Supplement will provide support for the Principal Investigator to maintain a
consistent level of effort needed to finish recruiting the 56 additional participants needed to complete her RCT
and continue her role leading all aspects of this research project. Additionally, the Administrative Supplement
will support the Principal Investigator in engaging in career development activities and receiving critical
mentorship related to closing out a mental health intervention project of this scope. Finally, the Administrative
Supplement will ensure the return on investment for this important research, as completing the RCT is
essential for understanding the effectiveness and acceptability of this innovative mental health intervention
delivery model that has great promise for improving access to evidence-supported depression treatment in
underserved rural communities.

Public health relevance
Project Narrative Public Health Relevance Statement: Rural residents in the United States have faced decades-long mental health treatment access disparities and are significantly less likely to receive evidence-supported care compared to urban peers. The lack of infrastructure and mental health professionals in rural areas requires consideration of innovative ways to deliver evidence-supported treatment, including leveraging technology and collaborating with community-based non-mental health providers, to increase accessibility, acceptability, and sustainability of needed care. Adapting and packaging an evidence-supported depression intervention in a context-specific way by incorporating rural residents’ perspectives and treatment preferences, reducing practical barriers such as transportation and cost, and collaborating with informal providers within the de facto mental health system, has the potential to make a large impact by increasing access to care and ultimately improving the lives of rural residents with depression. The proposed Administrative Supplement will support our ability to complete this important research and realize the possible public health impact by assessing a promising model for increasing depression treatment access in underserved, rural communities that has potential for replicability and scalability.